Biobehavioral Issues in Physical and Mental Health

Project Summary
The primary objective of this program is to train predoctoral and postdoctoral research scientists
in integrated biobehavioral and sociocultural approaches to the study of mental health and
disorder, and comorbidities. The program trains scholars in the development and application of
theories and research in behavioral science, integrated with biological and social science, to
understand the etiology, progression and treatment of mental disorders and physical disease. The
primary program consists of didactic training, intensive supervised research, and a weekly
colloquia series. The three pillars of the program are: (1) A coordinated curriculum on biological
systems involved in psychopathology and health; (2) Training in state-of-the-art research methods
and quantitative techniques; (3) An emphasis on health disparities by ethnicity, race, culture, SES.
The program offers advanced quantitative training and mentored research training in translational
science including randomized controlled intervention trials, observational/survey research
methods, experimental research, and methods of studying immune, neuroendocrine,
cardiovascular, neural and genetic processes.Four predoctoral trainees in 2nd through 4th year of
studies, and two postdoctoral take required courses and select from electives and research
opportunities to create individualized, focused programs of training. The Director and two
CoDirectors and 16 affiliated faculty members from the Department of Psychology, the Semel
Institute for Neuroscience and Human Behavior, and other units on campus provide the training.
This interdisciplinary faculty is composed of a seasoned senior faculty group with a history of
collaborating in training and research and selected exceptional midcareer and junior faculty
members, who bring a rich array of funded projects, active research labs, interdisciplinary center
involvement, and methodological expertise to the program to provide rigorous training in research.
The faculty as a whole represents research expertise in specific psychological disorders (e.g.,
mood disorders, anxiety disorders, substance use disorders, schizophrenia) and physical health
(e.g., cancer, cardiovascular disease, maternal/child health, gerontology). Theory and research
on pathological processes as well as optimal health and well-being are represented. Cross-cutting
content areas include stress processes, emotion regulation/coping, social relationships, and
health disparities. Faculty research covers all stages of the lifespan from prenatal/fetal through
childhood, adolescence, adults and aging. Finally, core faculty are expert in the development and
evaluation of biobehavioral approaches to preventing and treating psychological and physical
health problems, and in dissemination and implementation science.

Public health relevance
Project Narrative Integrative multidisciplinary science training is much needed to understand and address the complex relationships of biological, behavioral, and sociocultural processes in their contribution to the crucial public health problems of mental disorders as well as psychological and physical health disparities in the population. The proposed training will produce a cohort of scientists for the next generation of cutting-edge basic and translational research.